Quantitative regulatory genomics: networks, cis-regulatory codes, and phenotypic variation

How do changes in DNA sequence impact organismal properties? This is a central question of modern
biology, and insights into it can help us understand, among other things, why patients respond
differently to the same treatment, or why some species exhibit behavioral properties not seen in
other species. A major hurdle in solving this ‘genotype-to-phenotype’ problem is our poor knowledge
of gene regulatory mechanisms underlying phenotypes and cellular processes, and how those
mechanisms are encoded in DNA. It also leads to severe difficulties in prioritizing
phenotype-linked non-coding variants (polymorphisms) for further investigation. Driven by these
challenges, my lab seeks to develop quantitative frameworks for describing and
discovering transcriptional regulatory mechanisms. We have made significant progress towards this
goal in two main directions: (1) We have developed detailed biophysical models of the
cis-regulatory encoding of gene expression. Using these models we have shown how the regulatory
function of transcription factor (TF) binding sites depends on their sequence and DNA shape, as
well as their ‘trans-context’, e.g., cellular concentrations of regulators, and
‘cis-context’, e.g., proximity to other TF binding sites and chromatin states. (2) We have
devised statistical models to discover TF-gene interactions from transcriptomic data, as well as
other types of ‘omics’ data if available. Working closely with biologists, we have applied these
models to understand phenotypes such as cytotoxic drug response in cell lines, behavioral response
to social encounters, and embryonic development. Building on the strong foundations of our
past work, I propose to establish a research program that studies transcriptional regulation
holistically at the cis- and trans- levels. Our new pursuits will include: (1) use of our
computational, sequence-level models to describe two data-rich mammalian regulatory programs, an
experimental collaboration to dissect the cis-regulatory logic of a key inflammation gene using
massively parallel reporter assays, and major advances in our modeling techniques; (2) new
machine learning methods for reconstructing networks of TF-gene interactions that explain
phenotypic differences, integration of cis- and trans-regulatory evidence from multi-omics
data, and collaborations to apply these methods in cancer pharmacogenomics and behavioral
neurogenomics; (3) a new probabilistic framework to combine traditional statistical scores of a
non-coding variant with quantitative predictions of its regulatory impact based on the
above-mentioned techniques. Explorations of new forms of synergy among these related goals of
network reconstruction, cis-regulatory sequence modeling and variant interpretation will be woven
throughout our research program.

Public health relevance
The proposed work will answer fundamental questions about molecular mechanisms underlying phenotypic differences between individuals, such as why different patients respond differently to the same drug. We will develop new computational methods for discovery of such mechanisms from a variety of genomics data sets. We will work closely with experimental biologists and use our tools to study important biological topics including cancer drug response, inflammation, and effect of estrogen on breast cancer.